High-Definition Characterization of the Persistence and Perturbation of the HIV Reservoir: Data Analytics & Modeling Core

PROJECT SUMMARY
HIV infection can persist long-term antiretroviral therapy as a reservoir of provirus integrated into host cell
genomes. The stability and activity of this reservoir depends on the complex interplay between viral and host
mechanisms. The overall goal of this P01 is to characterize the mechanisms of formation, persistence,
reactivation, and therapeutic responsiveness of the HIV reservoir in unprecedented detail. This will involve
generating high-dimensional and longitudinal single-cell and single-genome datasets. The role of the Data
Analytics & Modeling Core is to provide specialized quantitative methods to each of the research projects to
aid in the design and interpretation of the experimental studies. The Core will bring together analytical experts
contributing to each project to collaboratively plan, conduct, and interpret analyses. Core members will develop
and apply state-of-the-art bioinformatic methods to interpret high-dimensional biological data characterizing the
HIV reservoir. They will additionally develop and apply mechanistic viral dynamics models to understand the
mechanism of reservoir formation, persistence, and reactivation, with the long-term goal of predicting
outcomes of novel therapeutics. Overall the Data Analytics & Modeling Core will advance the goals of this
program project by building a more complete understanding of the causes and consequences of HIV reservoir
dynamics.